Trigeminal Modulation of Olfactory Responses in the Main Olfactory Epithelium

PROJECT SUMMARY
The olfactory and trigeminal systems are usually considered independent, but most odorants activate the
trigeminal system, and most irritants activate olfactory sensory neurons (OSNs). These two systems co-localize
in the olfactory epithelium and bulb and in different cortical areas. Trigeminal stimulation usually reduces
odor intensity perception, but it has not been established where along the olfactory pathway this inhibition
takes place or which physiological mechanisms are involved. The olfactory epithelium, where the olfactory
response is first generated, is a candidate locus to harbor this interaction. Here, OSNs are densely interspersed
with trigeminal peptidergic fibers. These fibers can be activated by most odorants, and they can release
different neuropeptides and ATP. These substances can mediate an inflammatory response, but they can also
play other roles. In particular, ATP is an important extracellular signaling molecule, which is involved in
neurotransmission in the peripheral and central nervous systems, as well as in the peripheral gustatory system.
ATP-sensitive receptors are found in the olfactory epithelium, on both OSNs and trigeminal peptidergic fibers.
However, peripheral trigeminal-olfactory interaction and the potential role of ATP as its mediator have not
been studied. Using electrophysiological recordings from the entire mouse olfactory epithelium and single
mouse olfactory sensory neurons, Aim 1 will clarify how trigeminal activation by an irritant can modify the
olfactory response to an odorant and will analyze how this affects responses of single and populations of OSNs.
The trigeminal potency of each odorant will be determined, clarifying whether this characteristic has a
significant impact on modulation of the olfactory response and its temporal dynamic. Aim 2 will address ATP
signaling in the olfactory epithelium, determining trigeminal ATP kinetics in response to odorants with
different trigeminal potencies and the role of ATP in modulating the odorant-evoked action potential firing of
single OSNs. ATP will be measured using an ATP biosensor. Aim 2 will also determine the role of purinergic
currents in olfactory response reduction by irritants, using single OSN recordings from the intact olfactory
epithelium. This project will thus provide a more accurate understanding of the role of the trigeminal system as
an integral player, together with the olfactory system, in olfactory perception. It will also fill large gaps in our
current understanding of a range of poorly understood mechanisms, including perfumery and food preferences
and odor and flavor persistence. And it will contribute to understanding the physiology behind pathological
variations of olfactory sensitivity, induced by trigeminal activation due to, for example, smoking, hazardous
work enviroment or migraine.

Public health relevance
PROJECT NARRATIVE In the mammalian nose two chemosensory systems, the trigeminal and the olfactory, mediate detection of irritants and odorants, respectively. These two systems are separate sensory modalities, but they also interact to influence the processing of the chemosensory information at multiple levels. This project will examine this interaction at the level of the olfactory epithelium to gain a better understanding of where and how these systems influence each other at the periphery.